Rapidly Adaptable and Mass-Producible Microscopic Chiplets for Minimally-Instrumented Respiratory Viral Screening

Project Summary
Objective: Respiratory viral infections affect millions of individuals each year. Conducting frequent
widespread viral screening tests can curb outbreaks by quickly identifying infectious persons. Unfortunately, no
screening diagnostic platform exists with the capacity to test hundreds of millions of people daily during a
pandemic. This proposal is the first step in developing a novel viral screening test to fill this gap. The assay will
consist of microscopic circuits containing field effect transistors with antigen-specific receptors that are sensitive
to particular viruses. These chiplets – barely visible to the human eye – will be powered by light and will transmit
data using a light emitting diode, such that a few can be mixed into an extracted sample and illuminated with a
handheld device to yield immediate results. This diagnostic will be scalable and inexpensive; millions of tiny
chiplets can be fabricated simultaneously. It will be minimally instrumented; an ordinary cellphone with a strobe
flash and camera will interface with the chips. It will be flexible, rapidly adaptable, and multiplexable; receptors
specific to different or emerging viruses could be immobilized on distinct circuits, allowing multiple diseases to
be detected simultaneously in a single patient sample. This diagnostic will thus be unmatched as a mass
producible, simple to use, adaptable, and high throughput tool for frequent and widespread virus screening.
Specific aims: The proposed diagnostic will be developed by pursuing the following specific aims.
1. Integrate biological field effect transistors into the existing optical wireless integrated circuit platform.
2. Develop a multiplexed detection scheme for interacting with optical wireless integrated circuits.
3. Demonstrate the test’s feasibility in a clinically relevant quantitative range using mock clinical specimens.
Career development plan and career goals: Dr. Matthew Campbell (Ph.D., P.E.) is a postdoctoral
researcher in the School of Engineering and Applied Science at the University of Pennsylvania, where his work
is focused on fabricating microelectromechanical systems. The proposed K25 career development award will
apply his nanofabrication skills toward biosensor development and extend his training and exposure into two
new domains: (1) biomedical experimentation, and (2) medical biology. This proposal contains a cohesive
mentorship and didactic strategy centered on these areas to accelerate his trajectory toward research
independence. Completion of this multifaceted training plan will position Dr. Campbell with the cross-disciplinary
skills and expertise necessary to become a leading investigator in the field of biomedical sensing diagnostics.
Mentors and environment: Dr. Campbell is enthusiastically supported by the university and his strong
mentoring team. His primary mentor is an expert in micromanufacturing (Prof. Igor Bargatin (Ph.D.)), and his co-
mentors bring extensive experience in microscopic circuits (Prof. Marc Miskin (Ph.D.)), field effect transistor
sensors (Prof. Charlie Johnson (Ph.D.) and Prof. Haim Bau (Ph.D.)), and viral respiratory tract infections (Prof.
Ronald Collman (M.D.). This group will provide the ideal training situation for Dr. Campbell to develop this assay.

Public health relevance
Project Narrative Viral respiratory tract infections such as influenza and COVID-19 cause substantial suffering worldwide. Though screening diagnostics, which identify infected individuals quickly before they spread disease widely, are an effective containment strategy during outbreaks, no testing platform exists today that has the capacity to check hundreds of millions of people daily. This study aims to develop a novel screening diagnostic based on mass-manufacturable microscopic circuits that detect viruses, which will enable nimble widespread testing during future pandemics.